HYPERBOOK FOR CANCER PREVENTION/HEALTH PROMOTION

DESCRIPTION: (Adapted From The Applicant's Abstract) The major goal of phase II is to develop an interactive cancer prevention software system for young adult communities on college campuses. Specific objectives include finalizing the design and plan system development; developing the content and functions of the system modules and interfaces and producing a pilot IBM compatible system; testing and evaluating it with faculty, students, educators, librarians, college computing professionals; adapting the design for Macintosh hardware; revising and finalizing the software for both IBM compatible and Macintosh platforms; and preparing for commercialization. The underlying goal of the project is to make cancer prevention interesting and meaningful to college age audiences whose interests lie elsewhere. The investigators intend to achieve this goal by relating cancer prevention information to their personal health concerns and their coursework in an innovative, instructional software package.